Aggregation of Deamidated Crystallins as a Major Cause of Cataracts

Project Summary:
Our laboratories have focused on the most prevalent chemical modifications that we have identified to be
associated with the insoluble proteins present in the nucleus of the lens- deamidation and oxidation. These
modifications are most relevant to age-related nuclear cataract, by far the most common type of cataract. In
this proposed work, we will examine the interplay between deamidation and oxidation in order to mimic the
age-related processes in the lens. Although the lens environment is normally in a reduced state, oxidation of
sulfhydryls in crystallins has long been associated with age-related cataract as the pool of lens glutathione
diminishes with aging in the center of the lens. The formation of non-native, disulfide crosslinked crystallin
subunits via the oxidation of Cys residues is therefore anticipated to be a key process leading to the
aggregation and insolubilization of lens proteins. In Aim 1, we will determine how specific, age-related
deamidations in γS promote its aggregation by identifying non-native disulfide bond formed in response to
combined deamidation and oxidation. In Aim 2, we will test the hypothesis that non-native disulfide bond
formation leads to higher ordered oligomers of γS. While the focus of Aims 1 and 2 is the oxidation of
deamidated γS, Aim 3 explores whether these age-related modifications in γS lead to non-native crosslinks
between γ- and β-crystallin subunits and thereby disrupt the native quaternary arrangement of the crystallins.
Overall, these findings will elucidate how deamidation, a spontaneous modification, contributes to the
oxidation-driven aggregation cascade that underlies age-related nuclear cataract. Establishing that
deamidation mediates its effects predominantly via augmenting the oxidation of crystallin proteins will provide a
robust model for the development of therapeutic strategies aiming to delay the onset of age-related nuclear
cataract by restoring the antioxidant levels of the lens. The work will also have significant implications for
several other diseases where deamidation and oxidation of long-lived proteins is associated with amyloid fibril
formation.

Public health relevance
Project Narrative: The major proteins found in the human eye lens are called crystallins and they become extensively modified during aging and cataract formation. These modifications include oxidation and a spontaneous chemical change, called deamidation. Our long-term goal is to determine how these modifications cause structural changes in the crystallins that lead to the large light scattering aggregates found in cataracts in order to intervene in the aggregation process and slow cataract formation.